SEMIColon: Somatic Exploration of Mosaicism in Colon

Project Summary/Abstract
If we understand the somatic mosaicism of healthy tissues and how this changes through
pathogenesis, we will be better equipped to screen for, monitor, and treat disease. Somatic mutations
play a central role in disease pathogenesis, from developmental syndromes to cancer, and there is growing
consensus that somatic mosaicism in healthy tissue influences fitness and disease predisposition. New
methodological breakthroughs enable the accurate detection of somatic mutations, mutation rates, and
mutational signatures. Establishing a biological baseline of mosaic profiles in healthy and diseased tissue can
facilitate the prediction of genetically-driven disease states and the optimization of disease management.
By studying somatic mosaicism in healthy and diseased colon, I will gain insight into colorectal
pathogenesis and establish a research framework to apply to other tissues. The colon is ideal for mosaic
research, given its monoclonal crypts, elevated mutation rate, and well-studied architecture. There are also
significant associations between somatic mosaicism and colorectal disease: somatic mutations are causative
in colorectal cancer (CRC) and are proposed to contribute to inflammatory bowel disease (IBD). These
diseases have well-established regional presentations, with distinct pathologies along the length of the colon,
such as “right” and “left” CRC and differently-clustered subtypes of IBD. However, the genetic etiologies
underlying these pathologies are unknown, given previous limitations in mosaic research. This proposal will
examine the spatiotemporal dynamics of colonic mosaicism in the context of healthy tissue and pathogenesis.
Evaluating mosaicism across the length of the colon will provide insight into whether region-specific
mutagenesis, either endogenous or exogenous, explains variation in regional pathogenesis.
A preliminary study by Lee-Six et al. reported variation in mutational signature proportions across the
colon. However, this analysis was limited by its low sequencing coverage (~15x) and examination of a small
number of colonic subregions in a small cohort. By leveraging access to cadaver tissue and colonoscopy
samples in tandem with biological and computational advances, I will quantify mosaicism with greater
resolution and capacity for hypothesis testing. This proposal will determine individual and cohort-based
mutational rates by anatomic subsite of the colon and extract mutational signatures that indicate
mutagenic processes, such as cellular proliferation or microbiome variation. I hypothesize that midgut-
and hindgut-derived colonic structures will harbor distinct mutational signatures from unique mutagenesis and
regionally distinct mutation rates. These mutational landscapes will likely overlap regionally with the
spatially-linked findings of CRC and IBD, suggesting a role in pathogenesis. Completion of this proposal will
then serve as an ideal framework to examine regional variation and pathogenesis in other tissues.

Public health relevance
Project Narrative Diseases of the colon are widespread, with colorectal cancer the 2nd leading cause of cancer death in the US and inflammatory bowel disease highly prevalent and rising in incidence across the globe. These pathologies have distinct presentations and outcomes across the length of the colon, but the genetic etiologies of these differences are poorly understood and limit precision treatment. By understanding how somatic mosaicism differs throughout the colon and disease development, we will be better equipped to treat these pathologies, better prepared to identify at-risk individuals, and better able to study tissue-specific disease progression in other organ systems.